Cancer Control Education Program

ABSTRACT
The UNC Lineberger Comprehensive Cancer Center seeks to renew its T32 Cancer Control Education
Program (CCEP, Years 31-35). During the next five years, the CCEP will continue to support five pre- and
three postdoctoral fellows yearly and train them for careers in cancer prevention and control that emphasize
multidisciplinary and collaborative research. Led by two co-directors, Drs. Kurt Ribisl and Melissa Troester, and
an interdisciplinary Steering Committee supported by four external advisors, the CCEP trains a variety of
fellows, including behavioral scientists, epidemiologists, and physicians in relevant disciplines. The program
has five objectives: 1) Understand the breadth of research in cancer prevention and control, with an emphasis
on acquiring methodologic skills for translating epidemiologic research into interventions; 2) Develop research
expertise by mastering a specific content area and demonstrating competency in discipline-specific research
methods as applied to cancer prevention and control; 3) Develop interdisciplinary collaborative capability by
learning the basic tenets and vocabulary of complementary content areas; 4) Gain mentored research
experience with the guidance of cancer-prevention and control focused preceptors and interdisciplinary teams
of mentors; and 5) Develop professional skills required for successful research careers, such as presenting
research findings, writing for publication, and securing research funding. The flexible training is tailored to suit
each fellow's needs and includes: a specialized core curriculum that includes coursework, integrative programs
(seminars, special workshops, journal clubs, etc.) and training in the responsible conduct of research; hands-
on research experience directed by teams of experienced faculty mentors; and professional development,
including experience in grant writing. Training lasts from two to three years, depending on progress and need.
Salaries and research/development allowances are designed to keep the CCEP fellowships among the most
desirable and competitive at UNC Chapel Hill. The outstanding research environment at the UNC Lineberger
features: well-funded and nationally recognized programs in Cancer Prevention and Control and Cancer
Epidemiology, close collaborations with the nationally recognized UNC Gillings School of Global Public Health
(as well as the Schools of Medicine, Nursing, Journalism and Mass Communication, and the College of Arts
and Sciences), and excellent core facilities. 23 Preceptors, selected for their strong records of advising and
research, are primary mentors. 17 Affiliates serve as potential co-mentors. The CCEP has had outstanding
success in training cancer prevention and control researchers. Among the 18 postdoctoral trainees who
received CCEP support during years 15 to 29, 12 (67%) are in research positions, including 9 (50%) in
academic faculty positions (4 associate professors, 5 assistant professors). [1 of 18 is deceased and 3 are still
in training.] Of the 43 predoctoral fellows who completed their CCEP support in the last 15 years, 36 (84%) are
in research positions, including 22 (51%) in postdoctoral fellowships or faculty positions [16 (37%) with
academic faculty appointments (5 associate professors, 11 assistant professors) and 6 (14%) in postdoctoral
fellowships].

Public health relevance
PROJECT NARRATIVE Given that over half of all cancer cases and premature deaths can be prevented, continued advances in cancer prevention and control depend on research that identifies, translates, and implements new knowledge from diverse areas -- from molecular discovery of prevention opportunities to community/provider interventions to increase use of prevention strategies to the adoption of public policy affecting tobacco use and other risk factors. Multidisciplinary training with exposure to a broad spectrum of ideas and mentored collaborative research is fundamental to the development of effective cancer prevention and control researchers. The UNC Lineberger Comprehensive Cancer Center Cancer Control Education Program (CCEP) is a pre- and postdoctoral fellowship training program that prepares fellows for careers in cancer prevention and control that emphasize multidisciplinary and collaborative research. Over the past 30 years, the UNC Lineberger CCEP has successfully trained 122 cancer prevention and control researchers with a multidisciplinary and collaborative focus. Over the next five years, the CCEP will continue its training of the next generation cancer prevention and control researchers.